Role of RTEL1 in Microhomology-Mediated End Joining

PROJECT SUMMARY/ABSTRACT
Double-strand breaks (DSBs) can arise in DNA from exposure to radiation and pollutants prevalent in our
environment. Inaccurate repair of DSBs can lead to genome rearrangements, which can cause intellectual
disability, neurodegeneration, immunodeficiency, and cancer. DSBs are removed by two major pathways:
nonhomologous end joining (NHEJ) and homologous recombination (HR), which are dependent on different
factors and are mechanistically very distinct. Importantly, DNA breaks can also undergo microhomology-
mediated end joining (MMEJ), in which limited homology in the ssDNA tails exposed by end resection triggers
DNA strand annealing to initiate end joining repair. MMEJ leads to deletion of the DNA sequence situated
between the regions of microhomology. As such, MMEJ is highly mutagenic, and is a hallmark of cancer cells.
The discoveries that MMEJ possesses a dedicated DNA polymerase, POLq, and that it is employed frequently
even when NHEJ and HR are intact support the premise that MMEJ is an evolutionarily conserved DSB repair
pathway.
Tumor cells deficient in NHEJ and HR rely heavily on MMEJ for viability upon treatment with chemotherapeutic
DNA damaging agents. Inactivation of MMEJ would thus sensitize tumor cells to such treatments. A major goal
of current MMEJ research is to identify novel factors that regulate or directly catalyze MMEJ, to define the genetic
and biochemical underpinnings by which they function, and to test their value as potential druggable targets. We
have identified RTEL1 as a novel factor that is required for efficient MMEJ. RTEL1 encodes an essential DEAH
helicase that disassembles various DNA structures including a key recombination intermediate, the displacement
loop (D-loop). We hypothesize that RTEL1 promotes MMEJ by dissociating D-loop structures that otherwise
compete with MMEJ. Our model explains several enigmatic observations regarding the inhibitory roles of HR
factors in MMEJ and provides a mechanistic framework for understanding the pathology of RTEL1-associated
diseases. We will test this innovative idea using a combination of molecular genetics and in vitro biochemistry.
This project will better define the mechanism of MMEJ and its regulation, and may reveal factors that can be
targeted to treat environmentally induced diseases such as cancer and neurological disorders. As such, our work
will exert a strong impact on environmental health research.

Public health relevance
PROJECT NARRATIVE RTEL1 is a DNA helicase that antagonizes homologous recombination by unwinding the D-loop structure. We have found that RTEL1 is required for efficient DNA break repair by the mutagenic MMEJ pathway. In this proposal, we will determine the mechanism by which RTEL1 promotes MMEJ using complementary molecular genetic and biochemical approaches. Given the importance of DNA break mechanisms in counteracting the harmful effects of environmental DNA damaging agents, the successful completion of our project will exert a strong impact on environmental health research.